Administrative Core

ABSTRACT:
The Administrative Core (Admin Core) of the program project “Mechanisms of the BRCA-network
in Tumorigenesis and Therapeutic Response” will effectively manage all aspects of the P01
program through an optimally organized administrative team, leveraging expertise in biostatistics
and pathology to ensure scientific rigor, fostering an effective communication environment,
overseeing proper appreciation of resources, and ensuring relevant polices are properly followed.
The Admin Core will accomplish these goals through four specific aims. Aim 1 provides a
management structure with a well-qualified core Leader and a Co-leader, an Executive
Committee composed of leaders of the research projects and the shared resource cores, an
Advisory Committee composed of internal and external members with strong scientific expertise
and experience in program management, and a program coordinator. A clear chain of command
is built in this management structure. Aim 2 provides strong statistic and pathological expertise to
the program investigators. This ensures unified high standards of research rigor. Aim 3 ensures
effective communication among the investigators, NIH program officers, institutional
administrators, the scientific communities and the general public. Aim 4 will work with institutional
financial officers to ensure that the fiscal aspects of the project are soundly managed.

Public health relevance
Public Health Relevance Statement: The Administrative Core (Admin Core) is developed to serve as the central point of contact for all matters of the P01, including, but not limited to, scientific and financial operations, preparing progress reports, organizing program retreats, data dissemination, etc. This will be accomplished by a team of experienced investigators and administrators.